Stem Cell Competition in Skin Homeostasis and Premalignancy

Project Summary/Abstract
Cell competition is a fitness-sensing mechanism where more-fit “winner” cells eliminate less-fit “loser” cells. First
described to optimize overall tissue fitness, cell competition can also give rise to cells with enhanced fitness,
such as those with oncogenic potential. These dual roles of cell competition may explain why oncogenic cells
can initiate tumors (oncogenic winners/wild-type (WT) losers), but also why they often do not lead to overgrowth
despite their accumulation in epithelial tissues (WT winners/oncogenic losers). However, it is unclear how losers
are eliminated or restrained, nor how winners identify and eliminate losers. Insight into the competitive cell-cell
interactions occurring during both homeostasis and premalignancy will thus fill a critical knowledge gap and
address a pressing need for preventing oncogenesis at early stages.
To address this hypothesis, I have preliminarily studied competitive interactions between a model for
premalignancy and their WT neighbors in the embryonic mouse epidermis, which harbors epidermal stem cells
(EpSCs) capable of acquiring oncogenic potential and is a well-characterized cell competition model. I observed
that sparse, premalignant EpSCs ectopically expressing SOX2 are actively eliminated by WT neighbors and
homeostasis is maintained. Interestingly, this loser status seems modulated by the degree of homo/heterotypic
interactions (HHIs), or who their neighbors are. In fact, SOX2 EpSCs shed their loser status and initiate
pathological overgrowth when SOX2 EpSC abundance in the tissue is increased. Armed with a premalignant
model that can behave like a winner or loser depending on their cellular “neighborhood”, I propose to
mechanistically dissect how these competitive statuses are assigned and further underlie homeostasis and
premalignancy. Aim 1 will address how SOX2 and WT EpSC losers are eliminated. Building upon my preliminary
data suggesting that intercellular adhesion is increased between SOX2 EpSCs in loser contexts, I will perform
in vitro assays and in vivo lineage tracing to assess resulting differentiation and/or anoikis. Aim 2 will interrogate
context- and contact-specific transcriptomic programs to uncover how SOX2 EpSCs eliminate WT neighbors
and vice versa. Using a lab-verified, in vivo contact-based tagging and purification system coupled with single-
cell RNA-sequencing, I will mechanistically decipher how winners identify and kill losers during both homeostasis
and premalignancy.
Completion of these aims will increase our understanding of the mechanisms underlying cellular fitness
in cell competition; uncover the inherent, tissue-level dynamics used to maintain homeostasis in the face of
premalignancy; characterize the very earliest stages of overgrowth initiation; and elucidate the “tipping point”
between epithelial homeostasis and oncogenesis.

Public health relevance
Project Narrative Cell competition homeostatically preserves and optimizes tissue function, but may also be hijacked by oncogenic cells. However, it is unknown how “winner” cells sense and attack “loser” cells, nor how losers are eliminated by winners. Using a premalignant model that switches between winner/oncogenesis and loser/homeostasis depending on who their neighbors are, I propose to use this model to dissect stem cell competition during both homeostasis and premalignancy.